Targeted Physical and Cognitive Activity in a VR Environment in Older Adults at Risk for Alzheimer's Disease

PROJECT SUMMARY
The overarching goal of this project is to use a novel virtual reality (VR) physical and cognitive
intervention aimed at improving brain health and cognition in older adults with mild cognitive impairment
(MCI), a risk factor for Alzheimer’s disease (AD). AD is the most common cause of cognitive impairment in
older adults and affects 36 million people worldwide. Results from several large pharmacological trials have been
sobering with no effective treatments for halting, slowing, or preventing the disease. Exercise has emerged as
an exciting, lifestyle intervention to help mitigate cognitive loss or delay the onset of dementia. However, to fully
leverage exercise benefits in this at-risk population, training the brain to learn and engage in a cognitively-
stimulating and physically-demanding environment may be key to effective therapies. Controlled cognitively-
challenging environments created in a VR setting provide an adaptable and safe environment for improving
cognitive dysfunction in older adults at risk for AD. While a large body of literature has found that exercise
enhances cognition, very few studies have coupled physical and cognitive activity in a VR environment,
simultaneously. By engaging and challenging spatial memory during moderate-to-vigorous intensity exercise
over time, memories for newly acquired information may be stronger and longer-lasting than either physical or
cognitive activity alone.
Therefore, in this project, we aim to use an integrated, ecologically valid, and meaningful physical and
cognitive intervention in VR that targets the hippocampus, a key region of interest in older adults at risk for AD.
We will recruit and randomize 150 older adults to participate in the intervention (combined physical and cognitive
VR program), active control (physical cycling only), or passive control (cognitive VR only) group to investigate
changes in cognition, brain function, blood-based biomarkers, and physical health in old adults (55-80 years old)
with early mild cognitive impairment. Results from this study will provide new evidence for the benefits of a novel
combined VR intervention that target physical and cognitive health, simultaneously.

Public health relevance
PROJECT NARRATIVE Using a neuroscientific approach grounded in the pathophysiology of Alzheimer’s disease, the proposed study will cross disciplines of neuroscience, health, and technology to investigate the effects of a targeted, simultaneous physical and cognitive activity intervention on brain health and cognition in individuals with early mild cognitive impairment. Results from this study will provide new evidence for a combined intervention to enhance cognition and brain health in older adults at risk for Alzheimer’s disease.